Confocal Microscope

Maldonado, Maricela; Confocal Microscope
Project Summary/Abstract
The acquisition of an Echo Confocal Microscope will provide a powerful tool for acquiring high resolution
three-dimensional (3D) immunofluorescence images for biological/biomedical applications within
California State University, Long Beach. Although conventional widefield microscopes enable high
resolution imaging of thin samples, the proper 3D reconstruction of thicker samples, such as cell-
embedded hydrogels or tissues, can only be completed by blocking out-of-focus light with a confocal
microscope. With an increasing demand in imaging of 3D structures, cells, and tissues for biomedical
research applications, an instrument capable of creating optical sections for 3D reconstruction is
essential. Faculty members in the biomedical engineering department currently have projects involving
the development of 3D biomaterials, microfluidics, and pancreas tissue/organoid development, which
would all greatly benefit from a confocal microscope for the visualization of 3D structures. In addition, the
Echo confocal is equipped with live imaging capabilities and reduces photobleaching by utilizing spinning
disk technology making data acquisition faster than traditional laser scanning confocal. The long-term
objective is to place the confocal microscope in a shared resource core microscopy/imaging facility
where faculty and students will be able to bring their samples to produce high quality 2D and 3D images.
Support of this core facility will enable/augment cross-discipline collaborative research within CSULB.
The user-friendly interface of the Echo Confocal Microscope will also accelerate the number of faculty
and students that can be trained for their research and/or educational projects. In addition, by housing
the confocal microscope adjacent to a classroom space the instrument will be readily accessible for
course laboratories and further provide additional hands-on-learning opportunities for students.

Public health relevance
Maldonado, Maricela; Confocal Microscope Project Narrative The versatility of using an Echo Confocal Microscope for the imaging of three-dimensional constructs has powerful implications in biomedical research and education at California State University, Long Beach (CSULB). Faculty and students will have access to an instrument that allows for live imaging of cells in the lab and/or examining 3D cell aggregate or tissue architecture which is essential for enhancing the cutting-edge research at CSULB. Importantly, the confocal microscope will provide additional hands-on educational experiences for students interested in biological/biomedical research fields.